GIBBS MOTIF SAMPLING--DETECTION OF BACTERIAL OUTER MEMBRANE PROTEIN REPEATS

The detection and alignment of locally conserved regions (motifs) in multiple sequences can provide insight into protein structure, function and evolution. A new Gibbs sampling algorithm is described that detects motif-encoding in sequences and optimally partitions them into distinct motif models; this is illustrated using a set of immunoglobulin fold proteins. This algorithm extends the previous work in this area (Lawrence, et. al. Science, 262:208-214, 1993) in three ways: 1) The requirement for the specification of the number of motifs in each sequence has been relaxed. 2) The length of the motif is now automatically determined by the algorithm. 3) A non parametric test for the significance of the alignment has been developed. When applied to sequences sharing a single motif, the sampler can be used to classify regions into related submodels, as is illustrated using helix-turn-helix DNA-binding proteins. This feature permits the algorithm to simultaneously align the sequences and classify segments into submodels. Other statistically-based procedures are described for searching a database for sequences matching motifs found by the sampler. When applied to a set of thirty-two very distantly related bacterial integral outer membrane proteins, the sampler revealed that they share a subtle, repetitive motif. Although BLAST (altschul et. al., 1990) fails to detect significant pairwise similarity between any of the sequences, the repeats present in these outer membrane proteins, taken as a whole, are highly significant (based on a generally applicable statistical test for motifs described here). Analysis of bacterial porins with known trimeric beta-barrel structure and related proteins reveals a similar repetitive motif corresponding to alternating membrane spanning beta-stands. These beta-strands occur on the membrane interface (as opposed to the trimeric interface) of the beta-barrel. The broad conservation and structural location of these repeats suggests that they play important functional roles.